Developing sulfonium lipid nanoparticles as a novel platform for mRNA delivery

SUMMARY
Lipid nanoparticles (LNPs) are the most clinically advanced system for mRNA delivery, as highlighted by the
FDA approvals of Spikevax® and Comirnaty®. However, there is no one-fit-all lipid design; lipids that perform
well for one application may not work effectively across different cell types or medical conditions. This
underscores the need to expand the lipid molecular toolbox to address evolving therapeutic challenges. By
introducing sulfonium as a charge-carrying unit to replace traditional amines, we first demonstrated the safety
and feasibility of using unconventional, non-amine-based sulfonium lipids for mRNA delivery. Building on these
promising results, we propose to further develop sulfonium lipid nanoparticles (sLNPs) as a new platform for
mRNA delivery. We will expand the chemical diversity of sulfonium lipids by incorporating novel building blocks,
laying the groundwork for structure-activity relationship studies. Similar to amine-based lipids, variations in the
head, linker, and tail structures of sulfonium lipids will likely affect self-assembly, cargo delivery, and
biocompatibility. A detailed mechanistic investigation will uncover the unique physicochemical and biological
properties of sLNPs. Additionally, we will explore the therapeutic potential of organ-targeting mRNA/sLNP
formulations for treating acute lung injury (ALI) and acute respiratory distress syndrome (ARDS) in clinically
relevant small animal models, providing robust preclinical evidence to pave the way for future translational
research of sLNP technology.

Public health relevance
NARRATIVE This research focuses on developing a new class of materials - sulfonium lipid nanoparticles (sLNPs) - as a novel platform for mRNA delivery, with the potential for improved safety, enhanced efficacy, and organ - and cell-specific targeting.